Molecular basis of circadian rhythms disruptions linked cardiometabolic disorders and their mitigation using dietary intervention

Project Summary:
Genetic and lifestyle perturbation of the circadian clock trigger cardiovascular diseases. The proposed
study will examine how aging, obesity and circadian rhythm disruptions linked with cardiometabolic disorders,
and how time-restricted feeding (TRF) mitigates these defects. The leading risk factors for cardiometabolic
diseases are age, shift work, energy dense diet and aberrant eating/sleeping patterns. Each of these factors
disrupts circadian rhythms, and it has been shown in model organisms that genetic perturbation of the circadian
clock increases the incidence and severity of cardiac diseases. For example, an aberrant eating pattern in
human, increases the risk of developing cardiovascular diseases by as much as 55%, after controlling for diet
and lifestyle, possibly by disruption of circadian clock. Also, mutations of circadian clock genes prone to cardiac
diseases and light-induced circadian disruptions further deteriorates cardiac abnormalities. Conversely, TRF
paradigm without reducing caloric intake has been shown to prevent various metabolic disorders and attenuates
age-linked cardiac dysfunction. However, pathogenic linkage of circadian clock disruptions with cardiometabolic
diseases, or the potential benefit of TRF intervention has not been assessed at the molecular or genetic level.
Thus, our scientific premise is that factors that affect circadian rhythms offer new avenues to understand the
etiology and attenuation of cardiometabolic disorders.
To address the mechanistic basis of this alarming public health issue, we have developed novel
Drosophila melanogaster (fruit fly) models to mitigate age, obesity and circadian disruption-induced cardiac
disorders by imposing feeding/fasting rhythms with TRF. Drosophila will serve as an excellent model system for
basic discoveries in circadian rhythms, energy metabolism and cardiac muscle physiology. Aim 1 of the proposed
study is to determine the molecular basis of the effectiveness of TRF in delaying age-, obesogenic challenges,
and circadian disruption-induced deterioration of cardiac physiology in Drosophila. Aim 2’s goals are to monitor
the effect of dietary intervention on the diurnal and long-term reprogramming of cardiac gene expression under
aging, obesogenic challenges and circadian rhythms disruption. Aim 3 will employ genetic validation of circadian
clock with other identified genes/pathways mediating the effect of eating pattern on cardiac health.
Our study will use hypothesis-driven experiments to address the molecular basis of the alarming public
health problem of age and obesity-induced cardiac dysfunction associated with circadian dysregulation.
Successful completion of this proposal will dramatically accelerate our understanding of the impact of daily
rhythms on cardiac muscle physiology. The TRF paradigm may prove applicable to human health through
application of community-based approaches to ameliorating obesity-induced comorbidities and thereby
improving cardiovascular and metabolic health.

Public health relevance
Narrative: Genetic and lifestyle perturbation of the circadian rhythm (known as body clock) and age pose significant health risks in triggering cardiovascular diseases. We will test the pathological link between circadian rhythm disruption with cardiometabolic disorders. We will also study how reinforcing the daily feeding-fasting pattern to orchestrate metabolic rhythms will improve metabolic health in an experimental model and our results may prove applicable to improving human cardiac and muscle health using community-based approaches.